Point-of-care C-reactive protein-based tuberculosis screening in people living with HIV: a randomized trial

PROJECT SUMMARY
Tuberculosis preventive therapy (TBPT) is among the most efficacious and cost-effective interventions to
reduce tuberculosis (TB) incidence and mortality among people living with HIV (PLHIV) but is grossly
underutilized due to our reliance on a symptom-based screening test to rule-out active TB. Studies from
Africa have shown that symptom screening has low specificity (10-30%) for active TB and does not meet the
minimum specificity (≥70%) requirement established by the World Health Organization (WHO) for TB
screening. The low specificity is a major barrier to TBPT scale-up because if current TB screening guidelines
were followed, 70-90% of PLHIV without active TB would not only be denied immediate initiation of TBPT but
would also require unnecessary and costly confirmatory TB testing. The overall objective of this application is
to evaluate the impact of a potentially more effective and cost-effective TB screening strategy, which is the
next step required for successful uptake of TBPT. Our central hypothesis is that compared to symptom
screening, a TB screening strategy based on C-reactive protein (CRP) levels, measured using a point-of-care
(POC) assay, will improve TBPT uptake, thereby reducing TB incidence and its associated mortality among
PLHIV. The scientific premise for this hypothesis is based on our own work that identified POC CRP as the first
tool to meet the minimum sensitivity (≥90%) and specificity (≥70%) targets established by the WHO for TB
screening. To accelerate scale-up of this promising TB screening strategy, and thus scale-up of TBPT, we
propose a single-center individual randomized trial to evaluate the impact of POC CRP-based TB screening in
1720 PLHIV initiating antiretroviral therapy from 3 prototypical HIV clinics in Uganda. Participants will be
randomized to either POC CRP- or symptom-based TB screening and followed for 2-years. Aim 1 will
determine whether POC CRP-based TB screening improves 2-year clinical outcomes. The primary outcome
for Aim 1 will be a composite of TB incidence and all-cause mortality. Key secondary outcomes include TB-
specific mortality and incidence of drug-resistant TB. Aim 2 will determine the impact of POC CRP-based TB
screening on intermediate outcomes related to the primary trial outcome. Primary outcomes for Aim 2 include
the proportion of PLHIV (a) initiating TBPT and (b) diagnosed with prevalent TB. Secondary outcomes include
the proportion of PLHIV (a) completing TBPT and (b) completing treatment for prevalent TB. Aim 3 will
compare the cost-effectiveness and projected epidemiologic impact of TB screening with and without POC
CRP. CRP testing will be performed using a low-cost ($2 per test), rapid (3 minutes) and simple (measured
from capillary blood) POC assay, increasing the likelihood that POC CRP-based TB screening will be
implemented in even the most peripheral settings. This research is significant because in addition to
quantifying the expected clinic, economic, and epidemiologic benefits of TB screening, this work may enable
the field to move beyond ineffective TB screening as a barrier to TBPT and improved outcomes of PLHIV.

Public health relevance
PROJECT NARRATIVE Systematic tuberculosis (TB) screening is recommended for all HIV-infected individuals living in TB endemic areas to identify individuals without active TB who are eligible for preventive therapy, an intervention proven to reduce both TB incidence and mortality. However, tests to rule-out TB perform poorly in people living with HIV resulting in millions of eligible individuals being denied this life-saving intervention. We plan to perform a clinical trial to determine whether a more accurate and efficient approach to TB screening – screening based on C-reactive protein levels – reduces TB incidence and mortality by increasing uptake of TB preventive therapy in people living with HIV. Because successful scale-up of TB preventive therapy has been projected to prevent hundreds of thousands of new TB diagnoses and save tens of thousands of lives, findings from this trial have the potential to have enormous clinical and public health impact and are essential for informing future TB/HIV policy.